Breast Oncology

The Breast Oncology Program (BOP), co-directed by Daniel F. Hayes, M.D. and Sofia D. Merajver, M.D., conducts basic, translational, and clinical research covering the spectrum of breast cancer. The BOP has six major scientific themes: 1) elucidation of the molecular mechanism of regulation of normal and malignant breast tissues and cells; 2) development of tools for diagnosis, prognosis, and monitoring; 3) development of novel therapeutic strategies; 4) evaluation of risk assessment and prevention strategies; 5) Improvement in quality of life and survivorship issues for patients with breast cancer; and 6) health services research. The BOP has 49 members from 11 Departments within.5 Schools of the University of Michigan, ensuring broad multi-disciplinary collaborations. Indeed, of the 397 publications by program members over this grant period, 20% were Intra-programmatic and 44% were inter-programmatic collaborations. Members of the UM BOP receive over $14,2 million In annual direct peer-reviewed funding of which $4 million Is from the NCI. During this period, BOP investigators have 1) characterized the breast cancer stem cell and conducted a phase 1 trial of chemotherapy plus a gamma secretase Inhibitor, 2) performed pre-clinical studies and Introduced a novel agent that inhibits the inhibitor of apoptosis proteins (lAPs) into clinical trial; 3) studied RhoC proteins, cancer cell matrix transport, epithelial-mesenchymal transition, and chemokine mediation of metastasis; 4) performed pre- and clinical studies of circulating tumor cells; 5) advanced understanding of transcriptional regulation, DNA repair, and cancer genetics, of breast epithelial tumorigenesis; 6) Identified translocations involving the MAST and NOTCH genes 7) demonstrated intrinsic subtypes that are resistant to adjuvant chemotherapy; 8) Investigated pharmacogenetics of breast cancer treatment; and 9) furthered the breast cancer survivorship and quality of life. The BOP has a major commitment to health services and outcomes research, with Important observations regarding patient decision. The BOP will continue these important pre-clinical, translational, and clinical studies in the upcoming funding period, particularly focusing on discovery of new diagnostic and therapeutic targets.

Public health relevance
The Breast Oncology Program is dedicated to research on the prevention, diagnosis, treatment and survivorship of breast cancer.